Conformational Regulation and Therapeutic Targeting of Oncogenic KRAS

KRAS is one of the most deadly, yet undrugged, cancer proteins and is present in over 30% of all human
tumors, with even higher frequencies found in pancreatic, lung, thyroid, colon, and liver cancers. Thus, achieving
new mechanistic insights into KRAS deregulation and advancing innovative approaches to neutralize oncogenic
KRAS remain among the highest priorities of the cancer field and represent the focus of this interdisciplinary
proposal. KRAS is a GTPase that serves as a critical control point for a host of cellular functions ranging from
cell survival and proliferation to endocytosis and motility. The functional activity of KRAS is dictated by nucleotide
exchange, with the GTP-bound and GDP-bound forms representing the on and off states, respectively. Cancer
cells hijack and enforce the activated state of KRAS through gain-of-function mutagenesis or gene amplification.
To date, small molecule approaches to directly block the GTP-binding site have been unsuccessful due to
subnanomolar engagement of GTP and GDP by KRAS. The structure of KRAS in complex with SOS1, a guanine
nucleotide exchange factor that enhances KRAS activity by facilitating GDP release, revealed a helix-in-groove
interaction potentially targetable by α-helical mimicry. We applied all-hydrocarbon peptide stapling to generate
stabilized alpha-helices of SOS1 (SAH-SOS1) and identified a prototype compound that engaged oncogenic
KRAS, including the broad diversity of clinical mutants, inhibited the ERK-MAP kinase phosphosignaling cascade
downstream of KRAS, and impaired the viability of KRAS-driven cancer cells. We found that not only did the
prototype SAH-SOS1 construct dissociate the catalytic SOS1/KRAS interaction as anticipated, but also directly
and independently blocked nucleotide association with KRAS by an unknown mechanism. Here, we aim to apply
chemical, structural, cellular, and in vivo approaches to interrogate just how a SAH-SOS1 peptide can directly block
the enzymatic activity of KRAS, compare and contrast this mechanism to the natural agonist activity of the SOS1
protein, and thereby inform both our structure-function understanding of SOS1/KRAS regulation and a new strategy
for therapeutic inhibition of KRAS in human cancer. To achieve these goals, we propose three experimental aims:
(1) Synthesize an expansive library of structurally-reinforced helices modeled after the KRAS-interaction domain
of SOS1 to identify the binding determinants and functional interactions with KRAS and its oncogenic mutants;
(2) Apply hydrogen-deuterium exchange mass spectrometry to elucidate the conformational effects of the SOS1
protein and SAH-SOS1 peptides on KRAS proteins and thereby define the mechanisms of enzymatic regulation;
(3) Advance optimized SAH-SOS1 inhibitors to cellular and in vivo testing in KRAS-driven cancers to validate
mechanism of action and therapeutic window, and provide proof-of-concept for clinical translation. By combining
the biochemical and mass spectrometry expertise of the Engen laboratory with the cancer chemical biology and
translational approaches of the Walensky laboratory, our goal is to provide new mechanistic insight into the
oncogenic KRAS pathway and inform a new modality to disarm it for therapeutic benefit in cancer.

Public health relevance
PROJECT NARRATIVE KRAS is one of the most prevalent and vicious cancer proteins, yet no drugs are available to inhibit its pathologic activity in human cancers. We have discovered that an all-hydrocarbon “stapled” peptide modeled after the KRAS-interacting helix of SOS1, a natural KRAS agonist, can inhibit oncogenic KRAS signaling by competitive dissociation of the SOS1/KRAS complex and, unexpectedly, by directly and independently blocking KRAS nucleotide association by an unknown mechanism. By combining the synergistic and interdisciplinary expertise of the Engen and Walensky laboratories, we aim to achieve new insight into the structure-function mechanisms of KRAS modulation by the SOS1 protein and SOS1- derived stapled peptides, and thereby advance a novel therapeutic approach for disarming KRAS in human cancer.